Phase III RCT of the Effectiveness of Silver Diamine Fluoride in Arresting Cavitated Caries Lesions

Summary
The proposed Cooperative Agreement is for support for a Phase III randomized clinical trial (RCT) to assess the
effectiveness of 38% silver diamine fluoride (SDF). SDF recently became available in the U.S., and is non-invasive,
inexpensive and simple to use for management of cavitated lesions exposing dentin clinically (i.e., holes) in primary teeth.
Early childhood caries (ECC) continues to be one of the most prevalent chronic conditions among U.S. children. It also is
one of the most common unmet healthcare needs of poor children (e.g., Head Start children). If allowed to progress
untreated for long periods of time, the disease can have broad dental, medical, social, and quality of life consequences.
ECC and severe-ECC (e.g., multiple cavitated lesions or at least one caries lesion in the anterior teeth, with onset at an
early age) is relatively inexpensive to prevent, yet becomes extremely burdensome on the children and families, and
expensive to treat once lesions cavitate (e.g., with stainless steel crowns, extractions, etc.). This is especially true in young
children who need extensive treatment, or are uncooperative and/or have immature cognitive functioning, disabilities, or
medical conditions, where treatment under general anesthesia, in most cases in hospital operating rooms, is the standard of
care. In 2016, the FDA issued a notice to health care providers that general anesthesia in young children can result in
permanent neurological damage and should be avoided. Thus, better strategies are needed to successfully manage
cavitated caries lesions in young children. The proposed RCT will be accomplished by targeting young children enrolled
in Head Start programs who have cavitated caries lesions that have exposed dentin clinically. Because of the
Breakthrough Therapy Status for SDF, FDA has been heavily involved in the design of this trial to ensure it will meet the
requirements for a cavitated caries lesion “arrest” drug claim, which is innovative in the U.S. The proposed protocol in
this application has been submitted by Advantage Silver Dental Arrest, LLC, holder of IND 124808, to the FDA as part of
our collaboration. In the first months of funding, we will work with NIDCR to review all relevant study documents and
manuals for the RCT, submit to IRBs, and calibrate all study examiners. Following this study preparation period, an
experienced research team will conduct a Phase III, multicenter, randomized, placebo-controlled superiority trial, with
two parallel groups involving a total of 1,040 children, 2-5 years old, who will be followed over a period of 8 months, to
assess: The tooth-Aim 1 (Primary study aim)- the impact of 38% SDF applied twice, 6 months apart, on arrest of cavitated
lesions in the primary dentition (assessed using the ICDAS II severity and activity criteria). Secondary aims will further
assess whether the provision of SDF impacts: the child-Aim 2 [effects of SDF on children's pain and pulpal infection],
and the family-Aim 3 [effects of SDF on oral health-related quality of life (Sub-Aim 3a), and treatment satisfaction and
acceptability (Sub-Aim 3b)]. The immediate impact and significance of this innovative project is that provision of and
access to a non-invasive, inexpensive, and simple to use alternative strategy to manage cavitated caries lesions for
children with limited access to care could profoundly improve oral health by arresting lesions, reducing pain, improving
quality of life, and significantly reducing costs, all contributing to substantial reductions in disparities in caries.

Public health relevance
Project Narrative: The University of Michigan, in collaboration with researchers at New York University, the University of Iowa, Indiana University, the University of Otago, and consultants from the University of Hong Kong and University of Maryland propose to implement a Phase III multicenter, randomized clinical trial (RCT), to test the effectiveness of 38% Silver Diamine Fluoride (SDF) in stopping the progression of cavities (i.e., large holes which result from dental caries, a common and debilitating disease) in the teeth of young children. Should the trial be successful, the impact would be a change in the standard of care and expanded access to a simple, non-invasive, inexpensive strategy to manage cavitated caries lesions in young children in the U.S., which otherwise are usually treated with potentially damaging general anesthesia and fillings or extractions. Access to this simple treatment should result in a reduction of disparities in access to care, and improvements in oral health, which addresses the NIDCR Strategic Plan Goal 3 [to apply rigorous, multidisciplinary research approaches to overcome disparities in dental, oral, and craniofacial health].